Label-retaining globose basal cells as neurocompetent stem cells of the olfactory epithelium

Project Summary The olfactory epithelium (OE) is chemosensory neuroepithelium lining the posterodorsal surface of the nasal cavity. This neuroepithelium is exceptional in its ability to provide constitutive neurogenesis and regenerate in bulk after injury. Despite the well-documented regenerative capacity of the OE, anosmia is reported in the majority of individuals over the age of 65 and has negative implications for quality of life, nutritional status, and safety. Histology of aged, anosmic human OE has revealed a loss of not only olfactory sensory neurons (OSNs) but the globose basal stem and progenitor cells that produce them. In this way, age- deponent olfactory neuropathology is the direct consequence of a failure in long-term tissue homeostasis attributable to exhaustion of neural stem cells. GBCs were historically recognized as a heterogeneous population of “active” neural stem and progenitor cells that are exceptional in their ability to provide constitutive OSN replacement and bulk regeneration, dynamically responding to the status of the epithelium. Recently a rare, quiescent subtype of GBC was discovered that retains thymidine labels, activates to contribute to post-injury regeneration via an unknown mechanism, and re-enters into quiescence after regeneration. These label-retaining GBCs (LR- GBCs) are analogous to other label-retaining cells observed, but poorly understood, in a number of epithelial tissues. The proposed aims seek to develop a mechanistic and molecular understanding of the regulation of LR-GBCs by leveraging the strengths of olfactory epithelium injury models and single-cell transcriptomics. The proliferation and potency of canonical GBCs are enhanced to repopulate the wounded epithelium when mature OSNs are selectively ablated, therefore it bears specifically testing whether LR-GBCs are regulated in a similar fashion. This proposal will investigate the overarching hypothesis that mature olfactory sensory neurons regulate the activation and quiescence of label-retaining GBCs, with the long-term goal of understanding how neural stem cells contribute to age-dependent neuropathology. This will be accomplished by answering the following three questions: Aim 1 ? Is a selective loss of mature OSNs sufficient for activating LR-GBCs? Aim 2 ? Are mature OSNs necessary for re-establishing LR-GBCs after injury Aim 3 ? What genetic programs are activated in LR-GBCs during the acute injury response?

Public health relevance
Project Narrative Globose basal cells (GBCs) are the active stem cells of the olfactory epithelium and are lost with age, leading to a high prevalence of anosmia and decreased quality of life in elderly populations. A rare, label-retaining subtype of GBCs contribute to regeneration after epithelial injury, however a lack of basic knowledge regarding these cells prevents then from being exploited therapeutically. By investigating the regulation of quiescence and injury-induced activation in label-retaining GBCs, the proposed experiments may lead to regenerative therapeutics that combat age-dependent olfactory dysfunction.